Center for Virtual Imaging Trial - Accelerated Validation Supplement

ABSTRACT
The Center for Virtual Imaging Trials (CVIT) serves as a premier national resource for in silico imaging
research, providing advanced computational phantoms, physics-based imaging simulators, and AI
development tools to support hundreds of users across academia, industry, and regulatory agencies. Virtual
imaging trials (VITs) enable efficient, rigorous evaluation of imaging technologies and protocols under
controlled conditions with known ground truth, offering a powerful complement to traditional clinical trials.
Maintaining this capability is critical for advancing diagnostic innovation, regulatory science, and precision
medicine.
This administrative supplement provides essential gap funding to sustain CVIT operations during a transition
period and to launch key advancements aligned with the Center’s original aims. These initiatives, which
address high-priority needs identified by the community, represent the first steps toward the next renewal
phase and focus on three areas of biologically realistic lesion modeling (a sub-aim from the anticipated TRD1
renewal), integrated PET-CT simulation (a sub-aim from the anticipated TRD2 renewal), and hybrid AI training
resources (a sub-aim from the anticipated TRD3 renewal).
Collectively, these efforts will sustain critical CVIT infrastructure while delivering tangible scientific advances
that expand its capabilities, enhance translational relevance, and position the Center for its next phase of
innovation. The proposed developments will ensure continued national access and leadership in simulation-
based imaging research and accelerate the development and evaluation of imaging technologies and AI tools.

Public health relevance
NARRATIVE This administrative supplement will provide critical support to sustain the Center for Virtual Imaging Trials (CVIT) as a national resource and to initiate key advancements that align with the original aims of the Center while representing important first steps toward its next phase.